P30 - Core Grant for Vision Research

ABSTRACT
Overall
The objective of the Core Grant for Vision Research is to provide support and facilities, which are not available
and cannot be obtained through individual grants, exclusively for vision research and NEI-funded projects at
Baylor College of Medicine (BCM). The Core also provides space, support personnel and equipment support to
facilitate state-of-the-art vision research and collaborations among vision research laboratories in the College.
The Vision Research Core at BCM currently has 24 vision research investigators, carrying 19 eligible NEI
RO1s, 1 NEI DP2, 1 NEI R21, 2 NEI T32s, 1 NEI U24 and 7 NIH RO1s from other NIH institutes, and their
research areas cover the structure, function and pathogenesis of the entire visual system, from the cornea and
lens to the retina and to the central visual centers. Their research disciplines include biochemistry, molecular
genetics, electrophysiology, genomic/bioinformatic analysis, psychophysics, computational visual neuroscience
and developmental biology. These investigators form a vibrant and highly interactive vision research group,
and have published more than 360 papers in the past 5 years, which have benefited from the usage of this
Vision Core. In this competing renewal application, we report our highly successful and productive past usage
of Core facilities, and seek continued support for four Resource/Service Modules: the Microscopy, Digital
Imaging and Histology Module, the Instrumentation Module, the Small Animal Visual System Analysis Module
and the Genomics and Bioinformatics Module. These modules contain equipment worth over $7M purchased
with Department of Ophthalmology and College funds. The Specific Aims of the Vision Core are: (1) To provide
scanning confocal microscope and electron microscope services for high-resolution three-dimensional imaging
of tissues and cells labeled with fluorescent dyes and for ultrastructural analysis of ocular and neural tissues,
and to provide histological facilities, services and training for both confocal and electron microscopy. (2) To
provide in-house, custom-designed machine, electronic, optics and computer services to the Vision Core
investigators who need special apparatuses that are not commercially available. (3) To provide access to
structural, physiological, biochemical, and behavior testing facilities, such as OCT, ERG, patch clamp
recording, water-maze, HPLC, mass spectrometry and OKR, to study mouse, rat and rabbit visual system
function, dysfunction, and structural/genetic defects. (4) To provide state-of-the-art genomic technologies and
critical bioinformatics support to Vision Core labs by leveraging the expertise, technologies, and resources of
the BCM Human Genome Sequencing Center. (5) To foster interactions and collaborations among various
vision research groups at BCM through shared use and training of Core facilities. (6) To provide a rich and
vibrant research environment to recruit and retain outstanding vision research faculty, students and
postdoctoral fellows; and to facilitate initiation of new and innovative vision research projects and programs.

Public health relevance
NARRATIVE Overall The Core Grant for Vision Research provides support and facilities which are not available and cannot be obtained through individual grants to 24 vision research investigators at Baylor College of Medicine, carrying 19 eligible NEI RO1s. The Core facilities are used to study how visual system disorders, such as retinitis pigmentosa, age-related macular degeneration, glaucoma, amblyopia and strabismus occur and to determine what neuronal and synaptic mechanisms in the visual system are responsible for the pathogenesis of these disorders.